Chloride channels in endothelial cells

Project Summary
Endothelial cells regulate a wide variety of vascular functions, including contractility, which modulates organ
blood flow and systemic blood pressure. A hallmark of virtually all cardiovascular diseases is dysfunctional
endothelial cells, but pathological mechanisms involved are uncertain. Several cation channels are expressed
in ECs that modulate arterial contractility, including small- (SK) and intermediate (IK)-conductance calcium
(Ca2+)-activated potassium channels and transient receptor potential channels, including TRPV4. In contrast,
physiological functions of anion channels in ECs are poorly understood. ECs express TMEM16A, a Ca2+-
activated Cl- channel, but whether this anion channel regulates arterial contractility is unclear. Similarly
uncertain is the pathological involvement of endothelial cell TMEM16A channels in the vascular dysfunction
that occurs during hypertension. Using a broad range of approaches, including tamoxifen-inducible endothelial
cell-specific knockout mice, we provide evidence that vasodilator stimuli activate TMEM16A channels in
endothelial cells to induce vasodilation. Preliminary data also suggest that endothelial cell TMEM16A channels
are dysfunctional during hypertension. In this proposal, we will investigate three specific aims. Aim 1 will
investigate the signaling mechanisms by which physiological vasodilators activate TMEM16A channels in ECs
to induce vasorelaxation. Aim 2 will examine the mechanisms by which the activation of TMEM16A channels in
endothelial cells elicits vasodilation. Aim 3 will study the hypothesis that hypertension is associated with
pathological alterations in TMEM16A channels in endothelial cells which inhibits vasodilation by these proteins.
Methods used will include molecular biology and biochemistry techniques, super-resolution
immunofluorescence microscopy, high-speed dual-inverted selective plane illumination microscopy (diSPIM),
two-photon confocal microscopy, patch-clamp and conventional electrophysiology, arterial myography and
radiotelemetry. This project will provide significant novel information regarding physiological and pathological
vasoregulation by TMEM16A channels in endothelial cells.

Public health relevance
Project Narrative Endothelial cells regulate arterial contractility. Dysfunctional control of contractility by endothelial cells is a hallmark of several cardiovascular diseases, including hypertension, but pathological mechanisms involved are poorly understood. We will investigate the novel hypothesis that TMEM16A channels regulate arterial contractility, investigate signaling mechanisms involved and test the concept that vasodilation mediated by these proteins is dysfunctional during hypertension.